CENTRALIZED OMICS RESOURCE (CORE) YEAR 4

Centralized Omics REsource (CORE) Technologies is a multiple award Indefinite Delivery Indefinite Quantity (IDIQ) begun in 2015 and provides IDIQ contract awards for whole genome sequencing and other omics measures, including DNA methylation, RNA expression patterns, and metabolic profiling. CORE, in conjunction with NHLBI's overarching TOPMed Program, seeks to discover factors and variants that influence disease risk, identify subtypes of disease, and develop more targeted and personalized treatments. Studies and proposed study designs and omics are selected via peer review and are approved samples supplied to one of eleven selected omics centers; the resulting raw and processed data is processed using TOPMed approved and designed pipelines and shared with originating studies, TOPMed PIs working in TOPMed domain working groups, and are also made available to NHLBI directed data repositories for sharing with approved investigators. TOPMed studies include multiple non-European (underrepresented populations) as well as studies that include or are entirely female.